Characterizing the Placenta-Brain Axis in Transgenic Mice Lacking Serotonin Transporter (SERT) in Trophoblast Cells

During pregnancy, the mouse and human placenta contain appreciable quantities of serotonin (5-
hydroxytryptamine; 5-HT), but a scant amount is known about the actions of this catecholamine within the
placenta. In the mouse, 5-HT is concentrated in parietal trophoblast giant cells (pTGCs) at the periphery of the
spongiotrophoblast layer and at the interface of the placenta and maternal decidua and may have local and as
yet uncharacterized paracrine effects. Concentrations of placenta 5-HT can be affected by extrinsic factors,
including selective serotonin reuptake inhibitors (SSRI) and endocrine disrupting chemicals, that can
detrimentally affect placental architecture and may render the fetus prone to diseases later in life. Thus, it is
essential to understand the source of 5-HT and paracrine actions of this compound within the placenta. In
mouse conceptuses where the 5-HT transporter gene (Scl6a4/SERT) is mutated, we have recently shown that
the pTGCs also appear to be targeted, but in this case, there is marked expansion, rather than shrinkage of the
pTGC layer, and upregulation of gene-sets involved in nutrient acquisition and metabolism and those linked to
blood clotting. We hypothesize that 5-HT exerts key paracrine actions within the placenta, pTGCs
acquire it via SERT from maternal sources, and disruption in pTGC accrual of 5-HT leads to placental
dysfunction and compromises fetal brain development. Relevant to these observations is that selective
serotonin-reuptake inhibitors (SSRIs), which block SLC6A4/SERT transport activity, are commonly prescribed
anti-depressants for pregnant women, and women using SSRI have been reported to deliver lower birthweight
infants and have placental-fetal vascular mal-perfusion, consistent with the inference that 5-HT might play a
role in placental homeostasis in the human. Based on these facts, we surmise that compromised
SLC6A4/SERT activity affects allocation of 5-HT within the placenta, thereby interfering with placental function,
including the ability to supply 5-HT to the fetal forebrain. To test our hypothesis that the pTGCs play a central
role in 5-HTapportionment, we have created conditional knockout (KO) mice that lack Slc6a4 /SERT selectively
in pTGCs and spiral artery TGC (Spa-TGCs), which may also be important for 5-HT accumulation by the
placenta. Specific Aim: We will determine whether disturbances in pTGC/Spa-TGC 5-HT acquisition via
SLC6A4 affect placental and subsequent brain development and function. This aim will address whether
mice that conditionally lack Scl6a4/SERT in pTGCs and Spa-TGCs have lowered accumulation of 5-HT and
develop placental and neural transcriptomic and histopathological changes. Experiments will confirm the role of
pTGCs in 5-HT accrual in the rodent placenta, help us understand how 5-HT availability affects the placenta
and brain, and whether maternal treatment with SSRI could obstruct such processes. Results may offer insight
into how placental abnormalities contribute to later-in-life diseases with a fetal origin, presumably paving the
way for novel early diagnostic and remediation strategies to prevent such disorders.

Public health relevance
Certain cells in the placenta called trophoblast cells may have similar functions as endocrine cells in the intestine that produce neurotransmitters that may benefit the placenta and regulate fetal brain development. This project seeks to how selective removal of the gene that allows the placenta to take-up serotonin affects placental and fetal brain development and may lead to long-term neurobehavioral disorders. Many pregnant women are taking selective serotonin reuptake inhibitors, which act on this same gene, to combat depression, and thus these studies may provide insight into how such drugs might affect the placenta and possibly increase the risk for neurobehavioral disorders, including autism spectrum disorders, in her unborn children.